Telomere-to-telomere assemblies of human genomes

Project Summary
Approaches to complete the human genome will benefit from careful, benchmarked advances that demonstrate
the capability to fully assemble and phase diploid chromosomes. The remaining unresolved regions in our high-
resolution genomic maps are known to contain long tracts of repeats. The long-term objective of our research is
to develop new experimental methods to complete chromosome scale assemblies to study the sequence
organization, structural diversity, and disease impact of these novel sequences. In our first aim, we demonstrate
the use of new approaches to generate the first telomere-to-telomere phased assembly of a human genome
using effectively haploid complete hydatidiform moles (CHMs), and demonstrate the ability to scale these
methods to a panel of CHMs. In our second aim we focus on validation methods of repeat assemblies to improve
upon the structural and base-level accuracy of our assemblies. In our third aim we harden haplotype phasing
method using high coverage ultra long data from diploid genomes to guide phased chromosome assemblies.
We propose to optimize a new, cost-effective method of improving high quality reference genomes to reach
complete, telomere-to-telomere genome assemblies. This research has the additional benefit that it will add new
sequence to the human genome to systematically explore genetic variation of regions frequently overlooked as
part of disease association and functional studies.

Public health relevance
Project Narrative The objective of the proposed study will be to develop innovative methods to reach complete, telomere-to- telomere phased assemblies of human genomes. To reach this milestone we propose technological innovation in both long read sequencing, novel repeat assembly strategies. Fundamental to the success of this project will be the equal emphasis on rigorous assessment of assembly structure and base-level accuracy.